Enhanced Program for Human Subject Protection

This application is in response to RFA OD-02-003 "Human Subjects Research Enhancements Program." The Joslin Diabetes Center is seeking to enhance its Human Subject Protection through this initiative to achieve the following specific aims. I. To create an in-house Institutional Review Board (IRB) Training Core that will develop, with the assistance of a professional team of educational consultants, curricula for all categories of personnel involved in human studies and establish resources for enhancements to the curriculum in the future. II. To create a tracking system for human subjects protocols by upgrading the current IRB database with utilities that will generate summary status reports and generate reminders regarding specific monitoring and oversight functions. III. To provide secure record storage facilities within existing research space by renovating currently unusable space.